Characterizing early signs of neurobehavioral dysregulation in infants at increased risk for behavioral disorders

Project Summary
Behavior dysregulation emerges early in life, is persistent, and often has lasting associations with more
intractable symptoms of child psychopathology. Attempting to isolate early risk factors is difficult due to the
varying presentations of behavior dysregulation, including comorbidities, differing developmental trajectories,
and varying responses to treatments. Consequently, it is vital to isolate early developmental risk groups by
characterizing early risk mechanisms in clearly identifiable subgroups at risk for behavioral disorders, such as
children with prenatal nicotine exposure. These children are at least 1.5 times more likely to develop attention-
deficit hyperactivity disorder ADHD, and often display early attention, motor, and sleep dysregulation
commonly associated with the disorder. Yet, the etiological pathways from infant risk factors to later behavior
dysregulation are unclear. Attention, motor, and sleep behavior are transdiagnostic constructs that are
hypothesized to underlie many behavioral disorders, including ADHD, and internalizing and externalizing
disorders. Thus, they may be important phenotypic markers predicting early behavior dysregulation. This
K99/R00 proposal will help to identify infants who may develop persistent behavior dysregulation from infants
exhibiting transient behaviors or no/low risk symptoms through multiple Research Domain Criteria (RDoC)
constructs. This project seeks to incorporate more sensitive, scalable, and automated measure to identify
behavior dysregulation earlier in development than current assessments allow. The first aim (K99) will leverage
integrative data analysis techniques to identify modifiable, RDoC-informed mechanisms that increase risk for
behavior dysregulation in toddlers. Through data aggregation and advanced statistical techniques, this project
will uncover meaningful insights from a large integrated cohort (N > 3,000) composed of multiple independent
datasets on nicotine exposure during pregnancy and neurodevelopmental outcomes from birth to 3 years of
age. The second aim (R00) will track trajectories and timing of attention, motor, and sleep behavior using early,
sensitive, and scalable measures to pinpoint risk for later behavior dysregulation in infants exposed to nicotine
in utero. For this aim, we will recruit a new sample of birthing parents and infants across the first postnatal year
(< 5 days old, and 4-, 8-, and 12-month-old infants) to characterize trajectories of attention, motor, and sleep to
determine how these trajectories predict risk for behavior dysregulation at 1-year of age. To accomplish these
aims, the mentored training will focus on furthering knowledge on the risk phenotypes of behavior
dysregulation, and data harmonization and advanced causal modeling. This project will provide advanced
training to support future research on using sensitive, scalable, and automated measures to detect risk for
psychopathology in early childhood. It will also aid in prevention and intervention efforts by isolating early
mechanisms of risk, as well as malleable behavioral targets, a NIMH priority (Strategic Objective 2.2).

Public health relevance
Project Narrative The proposed K99 study will leverage integrative data analysis to identify potential risk mechanisms (attention, motor, and sleep behavior) associated with behavior dysregulation in infants exposed to nicotine in utero and in unexposed infants. The R00 study will expand on this foundational knowledge to longitudinally characterize attention, motor, and sleep behavior earlier in development—across the first postnatal year—associated with parent-reported behavior dysregulation at 1-year of age, using sensitive, automated, and scalable measures. By charting these trajectories of risk, we can uncover the emergence of neurodevelopmental dysregulations and potential etiological pathways to help inform prevention and intervention efforts.